Biophysical and genetic cues regulating lipid droplet packaging and alterations in obesity

Summary
Obesity is a major epidemic, which affects one in three individuals in the United States. Extensive
remodeling of the adipose tissue and biogenesis of lipid droplets (LDs) occur in constant
overnutrition to store the additional fat. The biophysical and genetic mechanisms controlling fat
expansion are yet to be fully understood. Bile acids (BAs)—the body’s major natural surfactants—
not only facilitate fat digestion but also act as signaling molecules to regulate fat metabolism by
activating its receptors. Our preliminary data suggests that in response to BAs, LDs isolated from
brown adipose tissue (BAT, containing small multilocular LDs) remain the same size whereas
white (WAT, containing large unilocular LDs) adipose LDs integrate BAs in their core capturing
TAGs that can rapidly shuttle from droplet to droplet. We will test the hypothesis that LD ripening,
regulated by BA surfactants, is a dominant mechanism of LD growth instead of coalescence. We
also found that fat is packed in layers in LDs. Additionally, we found that the extracellular matrix
(ECM) of BAT is significantly more aligned that WAT’s ECM. We will investigate how the interplay
between fat and ECM packing is altered in obesity. Finally, we developed a giant unilamellar
vesicle (GUV) that mimics the endoplasmic reticulum LD biogenesis to tease these fat packaging
differences. Our pilot experiments show that TAG distributes evenly in the GUV membrane before
accumulating in a nascent TAG condensate. We will investigate a novel hypothesis for LD
biogenesis that, in addition to membrane-tension, is controlled by liquid-liquid phase separation.
We detected the presence of several BAs in adipose tissue and discovered that adipocyte-specific
knockout of Farnesoid X Receptor (Fxr)—a BA receptor—resulted in a larger LD size and
downregulated expression of genes controlling lipid metabolism. These surprising results indicate
that LD remodeling may be transcriptionally regulated through the BA-Fxr axis. Further, we
uncovered that a critical BA synthesis gene, Cyp27a1, was specifically induced upon
adipogenesis and that its deletion of Cyp27a1 in preadipocytes impaired growth, indicating an
important role of Cyp27a1 in adipogenesis. In addition to the focused approaches, we will also
investigate the alterations in the transcriptome and epigenome of adipose remodeling during the
development of obesity. Our exciting preliminary data underscores the importance of BAs' role
(surfactant and signaling) in regulating LD size and expansion. This proposal will (1) determine
how diet and BA regulation affect LD structure and biogenesis and (2) delineate the genetic
mechanisms that regulate LD expansion during obesity. Overall, this project will uncover
fundamental principles that govern LD dynamics in obesity.

Public health relevance
PROJECT NARRATIVE Obesity afflicts 93.3 million adults in the United States. Adipose tissue stores excess calories in the form of triacylglycerols and sterol esters packaged in intracellular lipid droplet (LD) emulsions. How obesity regulates LD expansion in different fat depots, and in particular in the presence of bile acid body surfactants, remains poorly understood. We propose an interdisciplinary approach to establish the biophysical and genetic cues for LD remodeling in obesity.